Development of a portable beat-to-beat fetal ECG system

Project Summary
There are 24,000 stillbirths per year in the United States, and 2.6 million stillbirths per year
worldwide, with no significant decrease in the last decade. Abnormal fetal heart rhythms, such
as long QT syndrome, are thought to play an important role in these deaths, and may cause 3-
10% of unexplained stillbirths. This is in addition to known fetal arrhythmias, which affect 1-3%
of pregnancies per year. A magnetocardiogram is the gold standard to detect these disorders,
but is not portable or practical for widespread use. Other available tools such as ultrasound and
cardiotocography cannot measure the intervals needed to diagnose and guide management of
life threatening arrhythmias. The ideal tool for diagnosing and guiding therapy for arrhythmias is
an electrocardiogram (ECG). Unfortunately, clinicians do not widely use the existing fetal
electrocardiogram (fECG) devices for a variety of reasons: they do not work throughout all of
gestation, can miss brief arrhythmias, have a delay between the actual rhythm and displayed
rhythm, do not work in multiple gestations, and lack resolution of important intervals.
Our team has refined a prototype fECG during an ongoing R21 funded study. This proposal will
build on our preliminary work to create a compact version of the fECG which can be utilized
more widely in ambulatory settings. In this proposal we aim to:
1. Develop a compact amplifier system
2. Develop a new user interface
3. Pilot test the new system in a cohort of ten pregnant women carrying fetuses 22-40
weeks gestation to determine whether it is comparable to or superior to the current
system in fECG quality and CTI measurements.
If successful, fetal cardiologists could use this tool to diagnose and treat known and latent fetal
arrhythmias. Globally, it could serve as a low cost tool to screen for arrhythmias that lead to
stillbirth and to monitor fetuses for compromise during surgery, maternal medication use, and
fetal interventions. Clinically implementing this critical diagnostic tool will be a landmark in the
field of fetal cardiology.

Public health relevance
Project Narrative Abnormal fetal heart rhythms, such as long QT syndrome, contribute to a significant percentage of unexplained stillbirths. The ideal tool for diagnosing and guiding therapy for these arrhythmias is a fetal electrocardiogram (fECG). We propose to transition our fECG prototype device to a portable clinical version by developing a compact amplifier, building a new user interface, and bench testing the new system in 10 patients.